Examining the Persistence of Neurocognitive Benefits of Exercise

Project Summary/Abstract
Physical activity (PA) is one of the most promising approaches for mitigating age-related cognitive decline and
risk for dementia, yet few sufficiently powered randomized clinical trials (RCT) targeting brain health outcomes
have been conducted. Further, little is known about the biological pathways and moderators of the brain
response to exercise. To address these gaps, we have conducted a multi-site, supervised, dose-response
(150min/wk of moderate-intensity; 225min/wk of moderate-intensity; 150min/wk of light intensity), aerobic
exercise RCT with brain health outcomes as the primary endpoints in 648 cognitively normal adults between
65-80 years of age. This study, Investigating Gains in Neurocognition in an Intervention Trial of Exercise
(IGNITE), was funded by the NIH in 2016. The RCT has been enormously successful in terms of exceeding
sample size expectations, maintaining high adherence and compliance (>80%), minimal missing data,
improving cardiorespiratory fitness, and achieving the expected distribution of under-represented minorities
(25% non-white). The results from IGNITE are bound to be transformative, but there will remain many
unanswered questions after the conclusion of IGNITE that we intend to address in this proposal. For example,
does a 12-month aerobic exercise RCT have any persistent or protracted benefits to cognitive, neural, or
neuropathological outcomes 5-years after the completion of the intervention? Was the RCT effective at
modifying long-term exercise behaviors? Can we utilize the rich participant data of IGNITE to forecast who is
more likely to maintain a physically active lifestyle after the completion of the intervention? How effective was
the exercise RCT for modifying the accumulation of Alzheimer’s disease (AD) neuropathology over a 5-year
follow-up? And, finally, if cognitive, brain, or markers of neuropathology are different as a function of group
assignment 5-years after the completion of the intervention, which factors mediate those long-term benefits?
The answers to these questions will have significant scientific and public health implications that we will
address in a cost-effective manner by conducting a 5-year follow-up evaluation of IGNITE participants. We
focus on 4 key aims and one discovery science aim: Aim 1: Test the effects of the IGNITE exercise RCT on
cognitive performance 5-years after the completion of the intervention. Aim 2: Examine the extent to which
participants maintained exercise behaviors 5-years after the completion of the intervention. Aim 3: Test
whether the intervention modified 5-year accumulation of AD neuropathology. Aim 4: Test whether the
exercise RCT influenced 5-year follow-up of neuroimaging markers of brain health. Discovery Science Aim:
Explore whether participant characteristics at baseline predict long-term engagement in exercise behaviors
after the completion of the intervention.

Public health relevance
NARRATIVE In this 5-year follow-up to the IGNITE exercise intervention study we will examine whether exercise has a delayed or protracted benefit to neurocognitive outcomes including Alzheimer’s disease neuropathology. We will also examine whether we can predict long-term exercise engagement by utilizing the rich biological and psychological data from IGNITE.